Implementation of a Shared Decision-Making Aid for Reducing Stigma against Drug Use and HIV Harm Reduction in a Rural Setting

NIDA RFA-DA-21-002: “Piloting a Shared Decision-Making Aid for Reducing Stigma in Drug Use and HIV
Harm Reduction in a Rural Setting”
Project Abstract
In the past decade, the US opioid crisis has emerged as a leading cause of death among adults. It has also led
to an increase in invasive bacterial and fungal infections; and HIV and HCV outbreaks in multiple regions.
Rural communities have had an especially disproportionate burden from the impact of opioid use disorder
(OUD). Treatment of OUD with pharmacotherapy is one of the most effective strategies for reducing OUD-
related mortality and morbidity. But while there has been increasing will for expanding pharmacotherapy,
stigma – from community, providers and patients—remains a significant barrier to uptake pharmacotherapy
and harm reduction. The approach to substance use has historically favored abstinence strategies that are
often without evidence, influenced by punitive, stigmatizing framework. This stigma may be even more
prevalent in rural communities. To date there have been very few effective interventions to address inter- and
intrapersonal stigma, and none with sustained effectiveness. We propose adapting and piloting a shared
decision-making aid for patients presenting to the ED or are being admitted at two hospitals in rural Missouri,
where there is a high prevalence of OUD and its complications. The decision-aid is an evidence-based
intervention show to increase knowledge, engagement and decision-making concordant with patient values in
a variety of medical conditions. It is feasible that by democratizing treatment and standardizing decision-
making counseling, the decision aid can mediate attitudes and reduce stigma. We hypothesize by delivering
standardized, high-quality knowledge to both provider and patient, we can reduce stigma in both. In Aim 1 we
will adapt an existing decision aid for OUD treatment to the specific context of rural hospital care. This decision
aid will be a part of an existing bundled care program for OUD and related infections that we have
implemented in these hospitals. In Aim 2 we will conduct a randomized pilot comparing the decision aid
intervention with counseling as usual without decision aid to assess feasibility, acceptability and preliminary
effectiveness for reducing stigma in substance use, HIV, OUD pharmacotherapy and harm reduction. We will
measure these around the time of the intervention and in longitudinal follow up. Our findings potentially could
identify a novel intervention and methodology for treatment expansion and stigma reduction that has not been
previously explored, especially in the rural context, where need is high. Following the successful completion of
this pilot trial, we will develop an expanded multi-site comparative effectiveness trial of the decision aid,
implementation studies, and cost-effectiveness analysis.

Public health relevance
NIDA RFA-DA-21-002: “Piloting a Shared Decision-Making Aid for Reducing Stigma in Drug Use and HIV Harm Reduction in a Rural Setting” Project Narrative A major barrier for the uptake of evidence-based interventions to address the ongoing opioid epidemic in the US, especially in rural regions, is stigma, which occurs at many levels, including that of the patient and provider. A shared decision making aid is an evidence-based method for increasing engagement and knowledge of both patients and providers, potentially democratizing treatment decisions, especially in stigmatized conditions. We propose to adapt and pilot a decision aid for OUD treatment and harm reduction in two hospitals in rural Missouri to evaluate whether this reduces stigma in both patients and providers.